The Pacific Cancer Research Consortium (PCRC), an NCORP Community Site

PROJECT SUMMARY/ABSTRACT
In 2013, the Pacific Cancer Research Consortium (PCRC) was created to bring clinical trials and
cancer care delivery research to community cancer treatment centers in the Western United States as
an NCI Community Oncology Research Program (NCORP) Community Site. Under a multiple PI/PD
structure, the 3 primary component sites—Swedish Cancer Institute in Seattle, Providence Portland
Medical Center in Portland, and Mountain States Tumor Institute in Boise—have facilitated the conduct
of NCORP-sponsored trials at more than 40 affiliate sites in Alaska, Washington, Oregon, Idaho,
Montana, and California. Over the past 5 years, the PCRC built on its collective experience in clinical
research, its shared organizational structure, and its diverse community demographics to achieve the
research and accrual goals of the initial round of funding. As an established NCORP Community Site,
for the next round of funding, the PCRC will continue to “bring cancer clinical research studies to
individuals in their own communities” by (1) developing clinically important trials and achieving robust
accruals that focus on underrepresented populations, (2) participating in cancer treatment, cancer
control and prevention, cancer care delivery research, screening, and imaging trials proposed by the
NCORP Research Bases, (3) optimizing and streamlining procedures to ensure timely and accurate
data submission and specimen collection, (4) enhancing the participation of minorities and underserved
populations by involving patient advocates, and (5) mentoring the next generation of community-based
cancer clinical trialists.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) The NCORP Community Site outlined in this continuation application comes from our experience building a multicenter infrastructure in the Western United States that excels in patient accrual and fosters new and close collaboration between investigators. We believe that our structure will accelerate the translation of knowledge gained from trials in cancer treatment, cancer control and prevention, cancer care delivery research, screening, and imaging into clinical practice and thereby enhance the science, the treatments, and the delivery of care to patients with cancer in community settings.